Admin Core

Administrative Core Summary
The Administrative Core will provide executive oversight, biostatistical support, and administrative support for all
of the Research Projects, PDX Core, Bioinformatics Core, Shared Resources Core and Pilot Project and Trans-
Network Activities Core that comprise the Washington University PDX Development and Trial Center (WU-
PDTC). The Administrative Core is responsible for fiscal and regulatory oversight for the WU-PDTC. The
Administrative Core will provide the communication infrastructure for the Projects and Cores of the WU-PDTC
and also with the PDXNet consortium and the NCI. To this end the Administrative Core will coordinate meetings,
working groups and perform other logistical tasks to support the WU-PDTC. The Administrative Core will also
support the Pilot and Trans-Network Activities Core with the solicitation for proposals for the WU-PDTC. Scientific
outreach to support the PDXNet and sharing of PDX models for clinical translation will be a primary goal of the
Administrative Core.